Single-Cell Analysis of Somatic Mutation Rates, Mechanisms, and Impacts in Human Ataxia Telangiectasia Cerebellum

PROJECT SUMMARY
Genome maintenance is crucial to cellular and organismal health. In conditions where DNA damage repair
(DDR) pathways are disrupted, patients develop severe multisystem disorders. While these diseases impact
distinct repair pathways, they share some phenotypic overlap, such as premature aging and
neurodegeneration. This observation suggests that genome instability promotes aging and neuronal death.
One such DDR disease is Ataxia Telangiectasia (A-T), a life-limiting DDR disease characterized by cerebellar
degeneration, immunodeficiency, and susceptibility to cancer. A-T is caused by biallelic loss-of-function (LoF)
mutations at the A-T mutated (ATM) locus, which encodes ATM kinase. A-T relevant mutations are thought to
interfere with one or more of its functions, most prominently ATM’s role orchestrating DDR and sensing
reactive oxygen species. Loss of these functions results in increased DNA damage and higher ROS in A-T
patient cells. Ataxia in A-T coincides with loss of cerebellar volume while sparing other brain regions. Histology
shows that Purkinje cells (PCs), the sole output of the cerebellar cortex, and cerebellar granule neurons die
over the course of A-T. Our preliminary data shows that deletion burden is higher in A-T neurons from the pre-
frontal cortex, but mutation burden analysis is lacking from disease-affected cell types. How ATM LoF impacts
PC genome stability, and consequently PC function and longevity, remains unknown.
I propose to characterize how ATM LoF impacts the PC genome and transcriptome at the single-cell level
in the human cerebellum. Post-mortem human brain was chosen over animal models because A-T mammalian
models fail to phenocopy human cerebellar pathology. This experiment requires a single-cell analysis because
PCs are very rare, comprising <1% of the cells of the cerebellum, so a “bulk” analysis would obscure PC-
specific patterns. A pure population of PCs is a prerequisite for single-cell somatic mutation analysis.
However, a robust protocol to isolate rare PCs for single-cell molecular analysis was lacking before I started
this project. To circumvent this hurdle, I adapted a technique to isolate soma from fresh frozen brain. I applied
PC soma to a new muti-omic protocol capable of capturing DNA and RNA from the same single cell to human
brain for the first time. Aim 1 will compare single cell DNA mutation burden between PC from A-T and matched
controls. Aim 2 will synthesize mutation characteristics – context, distribution, size (single base variants,
small/large insertion or deletions, structural variants) – into signatures. Signatures will suggest mechanisms.
Aim 3 will investigate the connection between DNA damage and transcriptional changes, linking genotype and
phenotype. Further, this work will provide the fellow with exemplary training in genomics, neurobiology,
statistics, and bioinformatics.

Public health relevance
PROJECT NARRATIVE This proposal aims to investigate the impact of ATM loss-of-function on cerebellar genome stability at a single- cell resolution, focusing on ataxia telangiectasia (A-T). By leveraging a novel approach to isolate Purkinje cells (PCs), which die over the course of A-T, from postmortem human cerebellar tissue, the researcher aims to identify and characterize somatic deletions in AT-derived PCs. Additionally, the study aims to establish A-T- linked mechanisms of PC DNA deletions, providing insights into the mutation spectrum, and to determine deletion impact on the transcriptome.